Microscopy Imaging Center for Research through Observation (MICRO)

Project Summary – CORE B: Microscopy Imaging Center for Research through Observation (MICRO)
The Microscopy Imaging Center for Research through Observation (MICRO) Core of the Integrative Center for
Environmental Microbiomes and Human Health (ICEMHH) will provide comprehensive imaging instrumentation
and technical expertise at the University of Hawaiʻi at Mānoa (UHM) to support research that characterizes
microorganisms and their relationship to each other, to host tissues or to their environment. The MICRO will
incorporate and enhance the existing Biological Electron Microscope Facility that houses the only transmission
electron microscope in the state, and the only scanning electron microscope at UHM supporting biological and
biomedical research. The MICRO Core will provide the following: instrumentation, training and services for
scanning and transmission electron microscopy, epifluorescent and confocal microscopy and laser
microdissection and optical tweezers. A major goal of the COBRE support will be to modernize equipment and
introduce users to new techniques, particularly rapidly changing fluorescent-imaging technologies, to assist in
studies of microorganisms and their microbiomes. Relocation of the MICRO Core to a new Life Sciences
Building, scheduled for completion in 2019, will provide a larger, custom-designed space for enhancing its
research and training activities. The MICRO Core will be available to researchers across the UHM campus, to
other local research and educational institutions, and to visiting scientists. The MICRO Core will favorably
impact COBRE investigators and their affiliates by providing essential infrastructure and expertise to advance
their research and foster collaborations that will positively impact the careers of junior investigators and more
established investigators. The MICRO Core will support the growth of the ICEMHH, and (i) bring it visibility
through its research and training efforts, (ii) staying abreast of advancing instrumentation and technologies in
microscopy, and (iii) facilitation of outreach activities to characterize Hawaii's microbiomes.